BLR&D Research Career Scientist Award Application

Osteoporosis (porous bone disease) is a disease of the skeleton that can have debilitating effects on many US veterans. An estimated 44 million Americans, or 55 percent of the people 50 years of age and older, are currently at risk for osteoporotic fracture. Improved treatment options for the disease require a greater under- standing of the cellular events and signaling pathways that control bone metabolism. My research program capitalizes on human diseases that result in very high bone mass. The genetic causes of these high bone mass diseases—craniotubular hyperostosis, sclerosteosis, van Buchem’s disease—provide insight into how bone mass can be manipulated in osteoporotic patients to improve their skeletal health and prevent fractures. Many of the high-bone-mass associated diseases are caused by mutations in a cell signaling pathway called “Wnt.” Thus, manipulation of the Wnt pathway holds great promise for skeletal health improvement. This path- way is particularly attractive as a therapeutic target because it can be manipulated to increase new bone for- mation, rather than simply prevent further bone loss (which is how all but one of the currently available FDA- approved therapies work). The long term goals of my research program are twofold: first, we seek to under- stand how the secreted inhibitors of Wnt signaling function as a coordinated unit (i.e., a milieu), by adjusting their expression levels when other members of the unit are adjusted (e.g., inhibited or deleted). Those adjust- ments in expression in the members of the milieu represent prime targeting opportunities to enact large changes in anabolic action in bone, as our supporting data suggest. We also seek to understand how this Wnt inhibitor milieu controls the anabolic action of mechanical loading—a potent anabolic stimulus that has lasting benefits to the skeleton. We seek to understand whether certain members of the inhibitory milieu func- tion as “homing signals” to ensure that new bone is added where it is needed most ? to the high strain regions of the bone, and that it is not added where it is not needed ? to the low strain regions of the bone. Again, our data suggest that the Wnt inhibitory milieu plays a significant role in this process. Our second goal is to con- duct functional studies targeting the Wnt inhibitor milieu, that have direct applicability to future therapeutic ap- proaches in patients. Bone wasting conditions such as mechanical disuse (e.g., bedrest, paralysis) and gluco- corticoid therapy (a drug used for treating inflammation and immunosuppression) are common among veter- ans. Based on measurements we and others have made regarding the changes in expression of Wnt inhibi- tors following disuse and glucocorticoid exposure, we hypothesize that the “compensatory milieu” of four Wnt inhibitors—Sost, Dkk1, sFrp4, and Wise—coordinate via unknown mechanisms to prevent anabolic action in the presence of disuse glucocorticoid therapy. We are actively targeting the entire milieu in different combina- tions, to determine whether we can restore anabolic activity in mice exposed to these bone wasting condi- tions. If so, those approaches would have far-reaching implications for the design of therapies aimed at treat- ing veterans with disuse- and glucocorticoid-induced bone deficiencies. Another goal we have defined, which also capitalizes on the biology of the Wnt inhibitor milieu, is to determine whether we can reduce the dose/ volume of Sost antibody required to generate a significant anabolic response by additionally blocking acces- sory Wnt inhibitors that are part of the compensatory milieu. We have already shown that we can dramatically increase the anabolic efficacy of Dkk1 antibody if we use it in the presence of Sost inhibition. We anticipate a significant osteoanabolic effect using much lower doses of antibody if we simultaneously block other accesso- ry Wnt inhibitors. The overall research program described addresses these questions in order to identify new ways to improve bone health among the Veteran population, and among the public in general.

Public health relevance
A million Veterans suffer from osteoporosis, while another 2.5 million are osteopenic. Worse yet, the burden is expected to rise given the senescing Veteran population. Beyond age, other lifestyle factors make Veterans particularly susceptible to osteoporosis, including increased prevalence of smoking, alcohol consumption, and physical inactivity. Moreover, many Vietnam and Desert Storm Veterans were exposed to environmental fac- tors that put them at much greater risk for developing bone and joint disease. Another issue facing many re- turning Veterans is spinal cord injury (SCI) and other battlefield-related injuries resulting in neuromuscular im- pairment. Those conditions result in disuse-osteoporosis, and progress made in neuromuscular rehabilitation can be offset or even nullified by degenerative changes in the bone. We are working on exciting new ap- proaches to preserving bone mass, structure, and mechanical integrity in the presence of neuromuscular im- pairment, which we believe will have significant translational capacity to impaired and osteoporotic Veterans.